BLRD Research Career Scientist Award Application

The overall goal of this Research Career Scientist award is to foster the nominee’s ongoing research program
that is focused on the study of extracellular vesicles (EVs) and their extracellular RNA (exRNA) cargo as
biomarkers and effectors of human health and disease including among Veterans. Through participation in a
national NIH-funded consortium research program, the nominee is working to develop novel methods to study
EVs and other carriers of exRNA for biomarker development projects. The nominee also recently reported the
first evidence of intercellular signaling between macrophage EVs and hematopoietic progenitor cells to control
the process of systemic and vascular inflammation and atherosclerosis cardiovascular disease.
Ongoing funding from a VA Merit grant is supporting the nominee’s goal of exploring the role of circulating EVs
isolated from Veterans treated for advanced vascular disease as biomarkers and contributors to disease
progression including via microRNA cargo. Experiments in the lab will also test if EVs produced from anti-
inflammatory macrophages can serve to control inflammation and atherosclerosis in diabetic rodent models.
Furthermore, funding from a VA Invention-based Supplement Award will support pre-clinical studies testing such
anti-inflammatory EVs as therapeutics to control cardiac inflammation and heart failure in a rodent model system
developed and patented for the VA by the nominee. Findings from these studies could provide much needed
new therapeutics in the form of EV-biologics to treat inflammatory diseases including in the cardiovascular
system that is a major healthcare need among the Veteran patient population.
The nominee’s internationally recognized program on EV biology has led to new collaborative research projects
with VA clinician investigators at the local and offsite stations. This includes a collaborative project to test EVs
produced by cultured stem cells as therapeutic mediators of skeletal muscle regeneration. Such studies have
been proposed in a VA Merit grant proposal with the nominee serving as co-Investigator, which is being revised
for a resubmission. The nominee is also engaged in collaborative studies with VA clinician investigators to
develop biomarkers of adverse outcomes of surgical procedures used to treat advanced vascular disease among
Veterans. Finally, projects proposed by the nominee through grants pending at the Department of VA and the
NIH make use of EV technology and expertise developed by the nominee to address the COVID19 disease
crisis. This includes by making use of new methods of EV detection in biofluids to develop biomarkers for clinical
outcomes of COVID19 disease. It also includes developing new forms of engineered EVs designed to serve in
improving host immune response against SARS-CoV-2 viral infection as well as to control lung inflammation.
Together, the award will serve to sustain the nominee’s momentum to developing a first-in-class research
program centered on the study of EVs as biomarkers and biologics to control tissue inflammation and remodeling
including in the cardiovascular system. It will also allow to expand the nominees network of collaborators with
clinician and basic scientists within the VA intramural research program, as well as at local, national and
international sites to widely disseminate and implement expertise in the study of EVs as biologics to improve the
diagnosis and treatment of diseases in priority areas to the VA. Furthermore, it will allow the nominee to increase
professional service to local and national committees including within the VA and maintain teaching and
mentoring to next generation research investigators and clinician scientists within the VA research program.

Public health relevance
This Research Career Scientist award will support the growth of a research program that is uniquely well suited to benefit the mission of the VA Office of Research & Development. It will do so by leveraging its internationally recognized expertise in the study of extracellular vesicles (EVs) to develop biomarkers and biologics for the experimental treatment of tissue inflammation and remodeling including in the cardiovascular system. The award will foster extensive collaborative research with clinician and basic scientists within the VA intramural research program, as well as at local, national and international sites to disseminate and improve its EV-based approaches to new biomarker and treatment development for diseases in priority areas to Veterans. This award will also lead to increased professional service to subcommittees within the VA, affiliate and other professional organizations, as well as to teaching and mentoring to next generation research investigators and clinician scientists within the VA research program to improve healthcare delivery to Veterans.